Predicting Tissue and Functional Outcome in Acute Stroke

Abstract
Stroke is a disabling cerebrovascular disease that causes 5.5 million deaths each
year globally. The disease progresses rapidly and irreversibly, leaving a narrow
time window for intervention. Existing methods for patient selection for endo-
vascular thrombectomy are suboptimal, based exclusively on simple linear
threshold models applied to neuroimaging. Deep learning has shown great
promise in recent years for many medical applications. We believe that it can
be used to integrate imaging and non-imaging data in a seamless and data-
driven way to improve stroke triage and clinical trials.
The goal of this project is to develop deep convolutional neural network
approaches to the initial MR and CT imaging, the most commonly performed
stroke imaging protocol in acute ischemic stroke patients, and to combine this
with non-imaging clinical information. We will train networks to predict the
most likely final tissue and clinical outcomes under 2 extreme conditions
(major reperfusion and minimal reperfusion) to estimate the treatment effect at
the individual level. Next, we use the methods and learning from this first study
to train deep learning models without using contrast perfusion imaging, which
will improve safety, cost, and time-to-treatment. Finally, we will test the
generalizability and explainability of these AI methods in external cohorts
which differ in terms of population and scanner types, including testing on data
from mobile CT scanners.
Accomplishment of these aims will fundamentally shift the acute stroke
paradigm beyond the relatively simplistic mismatch concept and replace it with
a data-driven method that takes into account the immense amount of imaging
and clinical data that can be brought to the stroke decision-making process.
The methods developed will improve long-term outcomes and reduce of the
cost of stroke care worldwide.

Public health relevance
Project Narrative Stroke is a devastating disease that progresses rapidly and irreversibly and requires important decisions to be made quickly in the context of both imaging and non-imaging clinical data. We will apply deep learning artificial intelli- gence methods to integrate these disparate streams of data to predict short- term tissue and long-term clinical outcome under the conditions of successful and unsuccessful reperfusion and perform studies to understand the general- izability and explainability of the AI methods. This will enable us to personalize triage pathways, reduce the time and cost spent imaging without losing valuable information, and better understand the underlying rationale of these predictions.